Deep-UV Microscopy for Real-Time Adequacy Analysis of Bone Marrow Aspirates

PROJECT SUMMARY/ABSTRACT
Cellia will improve the quality and reliability of bone marrow aspiration procedures by developing a point-of-care
instrument for rapid, non-destructive sample adequacy assessment. Our approach is based on a recently
developed label-free, deep-ultraviolet (UV) technique for cell imaging and analysis. Spicules, which indicate
sample adequacy, are easily identifiable in unstained, pseudocolorized UV images due to the spicules’ strong
light attenuation at 255 nm. The resulting deep-UV images can be generated in a fraction of a second and whole
slide imaging can be done in a few minutes, making the technique suitable for real-time use during aspiration
procedures. The deep-UV images are also nearly identical to the clinical standard Giemsa-stained slides, which
take over 45 min to process. Label-free, deep-UV imaging can be combined with machine learning (ML)
techniques for feature extraction and classification for automated quality assessment of aspirate smears in real
time without a pathology technician. Phase I work, using data from N=51 patients, met or exceeded all
milestones. This study demonstrated spicule adequacy assessment via visual assessment by a bedside
pathology technician (current state of the art at tertiary hospitals) achieved 87.2% sensitivity (SE) and 67%
specificity (SP), while automated assessment using deep-UV microscopy had improved SE (100%) and SP
(80%). The specific aims of this Phase II proposal are to: (1) Transition instrument control to a printed circuit
board assembly (PCBA) and optimize optical, electrical, and mechanical hardware; (2) Develop production-ready
software components including a user interface and ML training and inference; and (3) Integrate instrument
hardware and software and evaluate effectiveness of automated adequacy assessment on clinical samples.
Completion of these aims will result in a commercial-grade device with demonstrated safety and effectiveness.
Upon completion of this project, a limited battery of additional tests, primarily focused on reproducibility and
process validation, will fulfill the remaining testing requirements for to receive FDA clearance.

Public health relevance
PROJECT NARRATIVE Bone marrow aspirates are critical to the diagnosis, staging, and monitoring of hematologic conditions and cancers (e.g., leukemia, aplastic anemia, sickle cell disease, and metastasis of solid tumors), but 8-50% of the 700,000 aspirations performed annually in the US are unsuccessful due to operator technique, dilution of the sample by peripheral blood, or underlying pathology. Unsuccessful aspirate samples necessitate repeating the procedure, yet assessing which samples are successful/unsuccessful (i.e., adequate/inadequate) remains a clinical challenge and is often not done until many days after the initial procedure. Cellia will improve the quality and reliability of bone marrow aspiration procedures and reduce delays in diagnosis and administration of treatment by developing a point-of-care instrument for rapid, non-destructive sample adequacy assessment.